Iowa Biotech-TP: Predoctoral Program in Biotechnology

ABSTRACT
This application requests support for nine trainees for a Predoctoral Training Program in Biotechnology, the
University of Iowa Biotech-TP. These nine lines will be matched by six more lines by the University of Iowa
through its Center for Biocatalysis and Bioprocessing (CBB). Combined, the NIH and CBB fellowships will
provide training in the applications of biological and physical sciences to biotechnology-related research. The
CBB and Iowa Biotech-TP create a vibrant community of trainees and dedicated faculty trainers from four
University of Iowa colleges and ten academic departments. The Iowa Biotech-TP is administered by a
Leadership Team and an Executive Committee. An External Advisory Board of biotechnology industry leaders
provides independent input to assure relevance to the needs of the biotechnology industry and research.
Our Iowa Biotech-TP will train future leaders in biotechnology-related research and will equip them to succeed
in industrial, academic and governmental research enterprises. Our cohort of trainees will come from different
scientific and cultural backgrounds and will be trained in a way that fosters effective communication with one
another, which is critical to our ability to make significant advances in biotechnology in the future. The Iowa
Biotech-TP is designed to provide a deep and diverse education to trainees, including academic training
covering qualitative and quantitative aspects of biotechnology, hands-on introduction to industrial methods,
and preparation for professional life in biotechnology. Trainees are required to: a) complete an industrial
internship lasting three months; b) must complete at least three (3) semester hours of coursework in four of
five core areas of biotechnology (Biocatalytic Sciences, Bioprocessing, Molecular and Synthetic Biology, Data
Handling and Computational Analysis, and Professional Development); c) take courses in Responsible
Conduct of Research and Mastering Reproducible Science; d) participate in the “Perspectives in
Biotechnology” class and activities every semester including presentations at the annual CBB and the annual
Iowa Biotech-TP Spring Symposium; e) participate in TP's seminars; and f) participate in various trainee-
cohort career building and networking activities. Our fifteen proposed trainees (9 NIH and 6 CBB fellows) will
be selected annually toward the end of their first year in graduate school, and support for trainees may be
renewed for up to two years, however all trainees continue in the program until graduation. The recruiting pool
is based not on departmental affiliation but on interest in biotechnology and graduate training. In addition to
six fellowships, the CBB will provide administrative support, as well as financial support to offset the effort of
the Iowa Biotech-TP leadership team. The CBB will also provide training in industrial settings and will expose
trainees to commercial aspects of biotechnology. These CBB matching funds will greatly increase the
effectiveness of the funds requested from NIH and ensures an extensive industrial emphasis in training.

Public health relevance
PROJECT NARRATIVE Increased pace of research in pharmaceutical and biotechnology-oriented industries, increased venture capital investment in biotech start-ups, new technological breakthroughs including CRSPR-based genome editing, RNA-based vaccines, advances in computational modeling, new cell-based and animal models of human disease, etc., all generate a demand for a diverse pool of broadly, interdisciplinary educated PhD level scientists. The Iowa Biotech Training Program will fulfill this need by training future leaders ready for successful careers in industry, academia, and governmental research.